Improving Glaucoma Care Using a Scalable Decision Support System

PROJECT SUMMARY/ABSTRACT
Through the training outlined in this K23 award, Dr. Brian Stagg will become an independent investigator in
health services research using health information technology to decrease glaucoma blindness by enhancing
clinical decision making for glaucoma to ensure that patients receive appropriate glaucoma care.
CANDIDATE BACKGROUND: Dr. Stagg is an Assistant Professor specialized in glaucoma at the University
of Utah. Following ophthalmology residency, he completed a 2-year health services research fellowship at the
University of Michigan and earned a Master of Health and Healthcare Research degree, followed by a
glaucoma fellowship at Duke University. He has background experience in health services research, healthcare
delivery research, data science, and biostatistics. CAREER DEVELOPMENT PLAN: To succeed as an
independent investigator, Dr. Stagg needs additional training in: (1) Clinical Decision Support (CDS) system
workflow and implementation research, (2) CDS system design and human factors research, (3) CDS system
EHR integration using health informatics standards, and (4) research leadership and grant writing. The
training and mentorship outlined in this K23 will give Dr. Stagg this needed expertise. MENTORS: Through
the supportive research and mentorship environment at the University of Utah and his connections with
mentors from the University of Michigan and Duke University, Dr. Stagg has put together an innovative
interdisciplinary mentoring and advising team lead by Dr. Rachel Hess, his primary mentor. CLINICAL
PROBLEM: Up to 30% of patients who are actively treated for glaucoma continue to have significant visual
field loss and need intensification of treatment to lower eye pressure and prevent further loss. Proper
identification and management of such progressive visual field loss is vital to prevent blindness from
glaucoma. This is a challenge for clinicians caring for patients with glaucoma as they must incorporate large
amounts of longitudinal data from many data sources accurately and efficiently. Optimized, workflow-
appropriate CDS systems can help address this challenge. CDS systems present information to clinicians at the
point of care to improve decision making. SPECIFIC AIMS: Dr. Stagg will (Aim 1) understand differences
between ophthalmologic specialists and generalists in glaucoma clinical decision-making workflow and
workload, (Aim 2) iteratively refine the Glaucoma CDS System and evaluate its efficacy in a pre-clinical
setting, and (Aim 3) integrate the Glaucoma CDS System with the EHR and pilot for feasibility and usability in
clinics to deliver personalized recommendations to clinicians for visual field testing frequency. The completion
of these aims will result in (1) a rigorously developed, user-centered, scalable CDS system to help clinicians
determine a personalized visual field testing frequency for patients with glaucoma and (2) generalizable
knowledge that will support future CDS development for glaucoma and other eye conditions.

Public health relevance
PROJECT NARRATIVE Primary open angle glaucoma is a complex chronic disease that affects over 2.9 million people in the United States and is the 2nd leading cause of blindness in this country. Clinical decision making for glaucoma is challenging, as clinicians must incorporate large amounts of longitudinal data from many data sources, which often results in suboptimal testing and management. This study will lead to the development of a standards- based clinical decision support system that presents data at the point of care to help clinicians determine a personalized frequency for visual field testing for patients with glaucoma, which will reduce over- and under- testing and ultimately prevent vision loss.